Optimization of Antibiotics in Mothers and their Breastfed Infants Using Pharmacomicrobiomic and Metabolomic Analyses

Project Summary/Abstract
Pregnant people are particularly vulnerable to SARS-CoV-2 and at risk of developing a more serious or
complicated disease course, including about a 70% increased risk of death. Infection in pregnancy also appears
to be related to increased risk for preterm delivery as well as other adverse pregnancy outcomes, such as
stillbirth. For this reason, pregnant people are considered a priority population for vaccination. Limitations in the
design of existing clinical trials with pregnant persons and the lack of a comparison group in the V-Safe Registry
point to the urgent need for additional vaccine safety and efficacy data by trimester of vaccine exposure and
encompassing both short and longer term outcomes for pregnant people and their offspring relative to an
unexposed comparison group. With administrative supplement funding to parent award 1P50HD106463-01 and
using the established U.S. MotherToBaby pregnancy cohort study at UC San Diego, we propose to complete
new enrollment and follow-up of 900 COVID-19 vaccine exposed individuals (all brands, all doses, all trimesters
of exposure) and 900 unvaccinated comparators to evaluate pregnancy outcomes including major congenital
malformations, spontaneous abortion, stillbirth, preterm delivery, small for gestational age infants, postnatal
growth through one year of age. In addition, through one year post-partum we will compare the incidence of
SARS-CoV-2 infection post-vaccination in maternal/child pairs who were vaccinated in pregnancy to the
incidence of infection in gestational-age matched maternal/child pairs who were not vaccinated in pregnancy.
Finally, in a subset of 180 vaccinated individuals (60 per trimester of exposure) representing exposure to one of
the two mRNA vaccine products we will obtain blood samples following the last vaccination dose in pregnancy
in order to examine immune response in pregnancy. These data will provide essential safety and efficacy
information that can support COVID-19 vaccine-related public health recommendations in this special population.

Public health relevance
Narrative Pregnant people are particularly vulnerable to SARS-CoV-2 and at risk of developing a more serious or complicated disease course, including increased risk of maternal death and increased risk for adverse pregnancy outcomes such as stillbirth and preterm birth. Limitations in the design of existing studies point to the urgent need for additional vaccine safety and efficacy data by vaccine brand and trimester of vaccine exposure relative to an unexposed comparison group. The proposed study will provide this essential information, which would support COVID-19 vaccine-related public health recommendations in this special population.